Cellular and Molecular Features of Gene Mutations in Primary Ciliary Dyskinesia

Summary
The genetic syndrome primary ciliary dyskinesia (PCD) is characterized by defects in cilia motility resulting in
bronchiectasis, chronic sinusitis, infertility and cardiac malformations. Intense efforts over the past decade have
uncovered pathways required for cilia assembly and discovered genes that are mutant in PCD. The next goal is
to understand the specific cellular consequences of different classes of mutations to identify therapeutic avenues,
similar to the approach used for cystic fibrosis. Cilia motility is dependent on dynein motors, which are fixed in
large complexes on the skeletal axoneme of cilia. Genes that code for these dynein motors commonly harbor
PCD mutations. However, studies in model organisms and human cells have revealed that dyneins must be
prepared in the cytoplasm by dynein axoneme assembly proteins (DyAPs). We found that DyAPs colocalize with
dyneins in cytoplasmic foci of multiciliated cells. Mutation in DyAPs results in an absence of dynein motors within
the cilia and consequentially, impaired cilia function, also resulting in PCD. We have recently identified a subset
of DyAPs composed of HEATR2/SPAG1/DNAAF2, which form an early scaffold to function in an initiation phase
of dynein assembly. We propose that this scaffold engages with a second group of DyAPs, that we term the
folding phase complex, which carries out dynein assembly for transport to the cilia. We observed that mutations
in the initiation phase DyAPs result in the formation of cytoplasmic aggregates tagged with the proteostasis
adapter SQSTM1/p62, suggesting that abnormal protein processing leads to pathway interruption. Consistent
with this concept, these aggregates contain all three proteins of the initiation phase complex. We hypothesize
that mutations in DyAPs interrupt the complex function, lead to the formation of intracellular aggregates of non-
functioning machinery and a failure to move dynein motors to the cilia. We address this question with these aims:
(1) A functional analysis of human mutations of the initiation phase DyAPs to determine their effect on the
pathway related to the formation of aggregates, intracellular trafficking, and protein interactions with other DyAPs
and (2) a biochemical analysis to identify the composition of the aggregates and the associated activity of the
cellular proteostasis pathways to mitigate formation. Our goal is to identify factors related to the formation of
DyAP aggregates, determine how the DyAP pathway is interrupted and ask if aggregates formation can be
manipulated to rescue sufficient amounts of protein for function, as a first step toward conceptualizing a specific
treatment for one class of PCD mutations.

Public health relevance
Narrative Genetic defects of motile cilia that impair motor and structural proteins, cause cilia dysmotility, leading to recurrent infection and chronic lung disease. We found that mutations in early members of a pathway required for assembling cilia motor proteins form pathologic aggregates. We will characterize the effect of mutant proteins in this pathway, the nature of the aggregates and identify strategies to mitigate formation as a potential therapy.